Synthetic osteo-odonto-keratoprosthesis (OOKP, Tooth-in-Eye surgery)

Project Summary:
Osteo-odonto-keratoprosthesis (OOKP) or Tooth-in-Eye surgery is an exceptional procedure that can save
severely injured corneas. The OOKP procedure is effective and capable of treating corneas after multiple corneal
transplantation failures, or when the cornea is severely damaged by Stevens–Johnson syndrome, pemphigoid,
chemical burns, trachoma and multiple corneal graft failure.
The success rate in OOKP is high, however, it is an aggressive procedure, time consuming and involves partial
sacrifice of the patient's oral cavity. This proposal aims to simplify this surgery by making a novel OOKP synthetic
prosthesis.
At the first stage of the OOKP surgery, a patient's tooth and surrounding tissue are harvested to make an
autograft prosthesis called an osteo-odonto-lamina into which an optical cylinder is placed.
This construct is then implanted into a submuscular pouch for 2–4 months to be vascularized. At the second
stage of the surgery, the vascularized osteo-odonto-lamina is inserted into the eye to act as a frame for holding
a PMMA optical cylinder.
In this proposal, we build a special keratoprosthesis for the OOKP surgery as a replacement of the osteo-odonto-
lamina so the surgeons do not need to harvest teeth and surrounding jawbone of the patients.
For this purpose, we will follow the general design we have proposed in our recently issued patent. Although the
design and idea of the keratoprosthesis have already been proposed in our patent, it has not been produced,
and the details of the construct are yet to be configured in this proposal. More specifically, we are going to figure
out the material, density, porosity, and pore-size of the different parts of the prosthesis in a way to mimic the
details of the natural osteo-odonto-lamina structure, and particularly mimic the features of it that are accountable
for the success of OOKP surgery. We will use a titanium alloy and 3D-printing technique to fabricate this
keratoprosthesis.
By considering our criteria for mimicking such construct, we will make 18 samples. They will go through a full
physical, mechanical, and in vitro characterizations to find the most optimized synthetic OOKP keratoprosthesis.
In sum, OOKP surgery is a multi-disciplinary, labor-intensive, and invasive procedure requiring both dental and
ophthalmology expertise. Through the use of our new prothesis, the OOKP procedure can eliminate one very
aggressive stage of the surgery that harms patients and can reduce the overall length of the treatment by a few
months. It will considerably enhance the treatment of patients with severely injured corneas.

Public health relevance
Project Narrative: Osteo-odonto keratoprosthesis (OOKP) or Tooth-in-Eye surgery is an effective treatment for end-stage corneal diseases. The success rate in OOKP procedure is high, however, it is a very aggressive surgery in which a patient's tooth along with its adjacent tissue is removed to make a special prosthesis (known as osteo-odonto- lamina) for the procedure. In this proposal, we make a synthetic prosthesis to mimic the osteo-odonto-lamina to eliminate the aggressive part of the surgery.